3D Printed Airway Splints: Pre-clinical and Clinical In Vivo Degradation and Tissue Response

Abstract
Tracheobronchomalacia (TBM) in children is a congenital or acquired deficiency of
tracheobronchial cartilages that causes dynamic airway collapse, respiratory difficulties, and, in
severe cases, acute life-threatening events and death. A previous study tested a bellowed 3D
printed polycaprolactone (PCL) airway splint (denoted Airway Support Device – ASD) to treat
TBM with a solid arch under fatigue in vitro, in a Yucatan swine in vivo model for 1 and 2 years,
and lastly to treat patients with TBM under FDA Expanded Access clearance. Both in vitro
fatigue and in vivo results demonstrated that this design had a risk for fracture under growth,
and in addition restricted airway growth in the pre-clinical animal model. The goal of this
proposal is to 1) develop new flexible ASD designs that allow radial and longitudinal growth
while reducing fracture risk and 2) develop a new computational simulation combining growth,
degradation and PCL elastic-plastic damage models to predict airway growth and ASD damage
both in a pre-clinical model for Aims 2 and 3 as well as for a clinical model in Aim 4. It is
hypothesized that a new auxetic design will allow more airway growth and show less damage
than the current ASD designs. It is also hypothesized that the new growth/degradation
simulation will correctly predict the effects of ASD design on airway growth and device damage.
Both hypotheses will be tested using a 6-month and 2-year large pre-clinical animal study.
Patient implantation to treat TBM will be continued under expanded access. Finally, data
obtained in this study will be used to support an Investigational Device Exemption (IDE) to the
FDA.

Public health relevance
Project Narrative This project proposes to test the hypothesis that a more compliant 3D printed Airway Support Device (ASD) designed to treat pediatric tracheobronchomalacia (TBM) will reduce tissue growth device fracture risk, and allow greater airway growth compared to a previous stiffer ASD design. This proposal will also test the hypothesis that a computational simulation incorporating growth modeling, plastic damage and material degradation can predict long term in vivo ASD performance and tissue growth. Finally, this proposal will provide GLP pre-clinical data to support an Investigational Device Exemption (IDE) application and support continued Expanded Access clearance by the FDA to treat patients with TBM.